Macrophage NR4A nuclear receptors in tuberculosis pathogenesis

PROJECT SUMMARY
Alveolar macrophages (AMs) are a critical cell population in the homeostasis of the lung, needing to clear
pathogens and debris from the alveoli without compromising long-term lung health. However, our
understanding of their unique phenotype and cellular pathways remains incomplete. This is despite their great
importance in diseases such as tuberculosis (TB), in which Mycobacterium tuberculosis (M.tb) carves out its
niche inside these cells. As one of the leading causes of death from a single infectious agent and becoming
increasingly drug-resistant, there is an urgent need for new therapeutic approaches against TB. The overall
goal of our laboratory is to identify intracellular master regulators of inflammation and metabolism that dictate
human macrophage responses to M.tb and exploit them as potential host-directed therapy targets. Our lab has
identified an understudied family of nuclear receptors, the NR4A family, that is highly expressed by human
AMs. Previous work as well as our own data reveal a connection between these transcriptional regulators and
expression of surface lipid scavenger receptors (SRs) implicated in M.tb pathogenesis. NR4A members are
upregulated in response to M.tb infection of macrophages and function to control M.tb growth. The proposed
research plan will use a newly developed AM model to investigate the hypothesis that one or more NR4A
family members negatively regulate SR expression and therefore lipid uptake, and decrease M.tb growth in
human macrophages. The Specific Aims are to: 1) Determine the role of individual NR4A family members in
SR expression and lipid uptake in human macrophage models, 2) Determine whether the NR4A family is
protective against M.tb infection using macrophage models, and 3) Establish how NR4A family members
regulate NFB and PPAR signaling pathways in mediating M.tb macrophage resistance. In addition, this
project uses CRISPR (to complement siRNA knockdown) for specific macrophage knockout of single family
members to decrease off-target effects. Investigation of the NR4A family may ultimately identify new,
druggable host cell targets for TB therapies. This research plan, under Dr. Schlesinger’s mentorship, affords
me the ability to learn new scientific techniques, new models to study infectious diseases, detailed data
analysis and the training to shape the direction of this project and my career. The training plan outlines career
development activities including opportunities to improve my scientific presentation and communication skills,
technical skills, critical thinking, and grantsmanship. The research and training will take place at the Texas
Biomedical Research Institute with a deep commitment to scientific training, evidenced by numerous journal
clubs, seminars and full support of the Texas Biomed Association for Trainees. Texas Biomed has various core
facilities, high containment research labs for M.tb work both in vitro and in mice and NHPs, and all resources
needed for excellent scientific training. At fellowship completion, I will be prepared to design and perform
research independently and move to the next phase of my training.

Public health relevance
PROJECT NARRATIVE Alveolar macrophages (AMs) are a critical cell population that have an important role in healthy lung function and lipid metabolism while also being the main cellular niche for Mycobacterium tuberculosis, the causative agent of tuberculosis (TB), a global health problem. We will use a novel model for human AMs to investigate an understudied class of transcription factors linked to AM function and TB. We seek to determine the role of the NR4A family of nuclear receptors in macrophage function and host defense against Mycobacterium tuberculosis infection in order to deepen our understanding of AM biology and aid in identification of novel targets for host- directed therapies against TB.